Comprehensive and non-invasive prenatal screening of coding variation

Abstract
Non-invasive prenatal screening (NIPS) involves assessment of circulating cell-free fetal DNA (cffDNA)
extracted from maternal plasma and the widespread clinical application of this technique to detect chromosomal
aneuploidies in pregnancy is now routine and the standard of care. While NIPS technology has advanced to
detect some targeted genomic abnormalities, current approaches are low-resolution and able to capture only a
small fraction of genetic conditions important to prenatal diagnosis. Our preliminary studies on 6 samples
suggest the feasibility of a high resolution non-invasive prenatal screen (hrNIPS), that can capture the vast
majority of pathogenic coding variation (SNV, indel, CNV). However, our results suggest that the ability to call
all types of variation can be improved through calibration of statistical models and development of new
techniques. Integration of phenotype data will allow interpretation and prioritization of identified pathogenic
variants.
Therefore, we will deploy hrNIPS on 100 samples with paired fetal exome sequencing data to develop and
calibrate methods over this large number of samples (Aim 1). We will call variation on these samples using the
improved methods and implement an infrastructure to capture systematic phenotypes in these samples using
the phenopackets schema (Aim 2). Further, we will use phenopackets and associated HPO terms to leverage
phenotype-aware algorithms to prioritize identified variants for further review. We will interpret all variation in a
clinical context using ACMG criteria and explore which types of variants might impact prenatal care (Aim 3).
Finally, we will investigate the potential added value of hrNIPS as a maternal carrier screen. In parallel with these
research aims, an exceptional team of seven mentors and advisors across disciplines, career stages, and
institutions will provide didactic training, hands-on research support, and regular opportunities for presentation.
Collectively, the ability to comprehensively assess coding variation in pregnancy with hrNIPS would allow early
and non-invasive pregnancy assessment for molecular diagnosis and has the potential to transform the standard
of care.

Public health relevance
Project Narrative The ability to develop a high resolution non-invasive prenatal screen (hrNIPS) that comprehensively surveys all coding variation for pathogenic variants would decrease morbidity associated with invasive testing and has the potential to transform maternal fetal medicine. The optimization and implementation of methods to call the spectrum of variation (SNV, indel, CNV) with hrNIPS and integration of systematic phenotyping will bring this approach closer to clinical use, contribute to the repertoire of variation associated with anomalies in pregnancy, and develop an infrastructure that can be applied to other projects.